Changes in the public health burden of tobacco use during the COVID-19 pandemic: the C4R Study

Summary/Abstract
Tobacco product use has been well established as a major cause of death and disease, yet the public
health burden of tobacco in the context of the COVID-19 pandemic – which has already killed more than 700,000
Americans and radically altered behaviors and health in populations across the world – remains incompletely
understood. Emerging evidence suggests that the personal and societal disruption of the COVID-19 pandemic
has led to changes in tobacco use patterns. Reports from early in the COVID-19 pandemic provided inconsistent
estimates of associations between tobacco use and risk of severe COVID-19, with some studies suggesting that
smokers were at lower relative risk. This application will characterize the impact of the COVID-19 pandemic on
tobacco use patterns and the association between pre-COVID tobacco use and the risk and severity of COVID-
19 illness.
We will test these hypotheses in the Collaborative Cohort of Cohorts for COVID-19 Research (C4R), a
nationwide study of 14 population-based multi-ethnic NIH funded cohorts, which is assessing self-reported
cigarette and e-cigarette use using standardized questionnaires in over 45,000 cohort participants in whom
extensive prior harmonization of pre-pandemic tobacco use patterns, socio-demographics, psychosocial factors,
and comorbidities over >1 million person-years of follow-up are available. C4R is also ascertaining COVID-19
cases via questionnaires, with active surveillance in a subset, and validating cases via SARS-CoV-2 serology
and protocolized events adjudication. C4R has already collected over 45,000 COVID questionnaires, over
10,000 dried blood spots for SARS-CoV-2 serology, and over 1,000 COVID-related events that are undergoing
adjudication.
In Aim 1, we will identify and examine changes in cigarette and e-cigarette status, intensity of use, and
product mix use during the pandemic period (2020-22) compared to pre-pandemic tobacco use trajectories
(1971-2019). These changes will be assessed in association with socio-demographics, psychosocial factors,
comorbidities, COVID risk mitigation behavior (including vaccination), and history of COVID-19 illness. In Aim 2,
we will assess whether COVID-19 outcomes, including post-acute sequelae of SARS-CoV-2 infection (PASC),
are associated with pre-COVID non-cigarette tobacco use patterns (pipe, cigar, and e-cigarette), with
comparison to cigarette use and never tobacco-use.
Accomplishment of the Aims will support targeted public health interventions to promote smoking
avoidance and cessation among groups at high risk of tobacco initiation or relapse. It will also provide valid
information on whether tobacco use increases the relative risk of adverse pandemic-era health outcomes, severe
COVID-19 or PASC, which will be suitable to inform public health policy and regulation.

Public health relevance
Project Narrative This application will characterize COVID-19 pandemic related changes in tobacco product use and tobacco- related health outcomes in a US general population-based sample of over 45,000 US adults. The findings will be suitable to inform public health campaigns to promote smoking avoidance and cessation among groups at high risk of tobacco initiation or relapse during the pandemic period. It will also provide urgently needed information on the health risks of tobacco use during the pandemic period, including if, and to what extent, tobacco use increases the risk of severe COVID-19 or “long COVID”, which will be suitable to inform public health policy and regulation.